Treatment Development & Evaluation Core

TREATMENT DEVELOPMENT AND EVALUATION CORE PROJECT SUMMARY
Digital therapeutics hold great promise in overcoming the substantial challenges in accessing high quality,
empirically supported treatments for substance use disorders (SUDs) and co-occurring mental or physical
health conditions (CODs). Digital innovations can enhance the potency of existing interventions, extend their
reach, and reduce costs. Digital biomarkers from behavioral and physiological monitoring using smartphones
and wearable sensors (i.e., passive sensing) can improve specificity of assessment processes that in turn can
provide personalized targets to optimize interventions. Supporting the development of digital therapeutics is
vital, as most persons with SUDs do not receive SUD treatment, and of those who do receive treatment, only a
minority of treatments are evidence-based. Over the past 9 years, the Treatment Development and Evaluation
(TDE) Core has supported activities that enhance and expedite research on an array of technologies that can
improve treatment delivery. Our Core affiliates’ research has advanced the feasibility, acceptability, usability,
and efficacy of innovative digital health assessment tools and interventions for multiple types of SUDs among
diverse populations. These projects have also improved our understanding of developmental, and maintaining
factors, and mechanisms of change for SUDs. In the proposed renewal period, the TDE Core will continue to
enhance the quality, efficiency, and impact of research projects among an interdisciplinary expert faculty. The
Core will continue with, and expand activities for, sharing resources among CTBH affiliates and the greater
scientific and clinical communities (Aim 1), and provide mechanisms to support the acceleration and
accumulation of science that will enhance our understanding of factors that can optimize digital therapeutics for
SUDs and CODs (Aim 2). These efforts will embrace the 5 new CTBH priorities (e.g., scaling of digital
therapeutics, digital measurement to inform personalized just-in-time adaptive interventions (JITAIs),
integration of CODs and transdiagnostic mechanisms and interventions, digital health ethics, and inclusion of
underrepresented minority populations). For example, we will enhance our consultation services for preparing
competitive grant applications by expanding the array of Advisors with expertise in the priority areas, and will
refine the focus and enhance the intensity of our educational activities by developing and delivering webinars,
tutorials, and cross-Core workshops that provide in-depth training on high priority research targets. The Core
will also engage affiliates with active or pending digital health projects to include additional research aims that
address our new priorities. e.g., add common metrics of outcomes related to scaling, mechanisms of change,
or transdiagnostic processes; include passive sensing assessment to collect digital phenotyping data that may
relate to substance use or relapse; and assess CODs in SUD projects to evaluate how they moderate
intervention effects and how transdiagnostic interventions impact outcomes. These efforts will accelerate the
state-of-the science of digital therapeutics for SUDs and related conditions across diverse populations.